Unraveling the Impact of Extracellular Vesicle-Loaded FXR1 mRNA on Re-educating Cancer Microenvironment

Abstract
This study focuses on ovarian cancer, a significant cause of mortality among women with gynecological
malignancies. The tumor microenvironment (TME) plays a crucial role in tumorigenesis, and our research
characterize the involvement of fragile X mental retardation autosomal related protein-1 (FXR1), an RNA binding
protein, in ovarian cancer progression. FXR1 is highly expressed in ovarian cancer due to the amplification of
chromosome locus 3q26 encompass FXR1. We discovered that FXR1 mRNA is encapsulated and enriched
within extracellular vesicles (EVs) produced by tumor cells. We hypothesize that specific nucleotide elements
in FXR1 mRNA interact with TSG101, which is an integral part of EV for encapsulating FXR1 into EVs.
We further demonstrated that FXR1 mRNA encapsulation into EVs are transported from tumor cells to the cells
in tumor microenvironment. We observed high level of FXR1-EVs in tumor resident macrophages due to the
phagocytic abilities of macrophages. Our recent work showed that FXR1 promotes the translation of oncogenic
proteins like cMYC in cancer cells. However, the impact of FXR1 in macrophages and other tumor associated
cells have not been characterized. Based on our data, we hypothesize that FXR1 upregulation in macrophages
is required for an overall increase in the translation (protein synthesis) of several mRNAs that are important for
macrophage polarization favorable for cancer progression. We also hypothesize that FXR1 promotes the
polarization of M2 macrophages, which exhibits tumor associated macrophage (TAM) characteristics and
express high levels of immune checkpoint proteins. Consequently, FXR1-EVs production and its incorporation
in macrophages resulted in T-cell inactivation and T-cell exhaustion. Unlike melanoma, lung cancer, and bladder
cancer, ovarian cancer exhibits poor responsiveness to immunotherapy, categorizing it as a less immunogenic
or 'cold' tumor. Taken together, our hypothesis posits that FXR1-EVs play a significant role in rendering ovarian
cancer less immunogenic. Therefore, elucidating the mechanism by which FXR1-containing extracellular
vesicles (EVs) selectively target macrophages, modulate their functions, and inhibiting this process could offer
novel opportunities to sensitize immunotherapy for cancer.

Public health relevance
Project Narrative This proposal aims to characterize the mechanism by which FXR1 mRNA is encapsulated into extracellular vesicles (FXR1-mRNA-EVs) and its impact on reprogramming macrophages to promote tumor cell growth and T-cell inactivation within the tumor microenvironment (TME). We will elucidate the direct impact of FXR1-EVs on recipient cells by identifying its targets for promoting immunosuppressive mechanisms favorable for tumor growth. Additionally, this study will examine the effect of silencing FXR1 to enhance the sensitivity of immunotherapy.